Glucocorticoid-regulated transcription networks in macrophage biology

Every day, billions of cells in the body undergo apoptosis and are cleared by ‘continual efferocytosis’ - a highly
efficient, immunologically silent process whereby professional efferocytes recognize, bind and ingest apoptotic
cells (AC), degrade large cargo in the phagosome while also recycling the membrane. Impaired efferocytosis
has been linked to many diseases including metabolic syndrome, diabetic ulcers and autoimmunity. A key cell
type that gives rise to efferocytes is macrophages, MΦ – versatile immune cells that can produce inflammatory
mediators to fight infection (M1) or, conversely, suppress inflammation, perform homeostatic functions and
repair injury (M2). Homeostatic polarization can be elicited by disparate stimuli, including interleukin-4 (M2IL4)
or glucocorticoids (M2GC). IL4 signals to transcription factor STAT6, which upregulates a critical driver of the
M2 state, KLF4. GC act through their cognate receptor, GR, which activates and represses hundreds of genes
utilizing various coregulators. Among them, NCoA2/GRIP1 has been implicated in both activities yet, how GR
or GRIP1 contribute to MΦ polarization remained obscure. We discovered that M2IL4 and M2GC transcriptomes
share a substantial overlap mirrored by a striking shift in chromatin landscape. This convergence occurred at
the level of GR and KLF4 transcription complexes and was integrated, in a signal-specific manner, by GRIP1
which served as a cofactor for both and unexpectedly, enabled KLF4 to act as an effector of GC-induced
polarization. These studies helped delineate M2 MΦ programming by ‘pure’ signals, however efferocytes are
functionally distinct as: 1) homeostatic stimuli co-exist in vivo yielding novel regulatory patterns, 2) ingested
ACs represent, uniquely, both signals to shape MΦ phenotype and a source of a large cargo to be metabolized
and recycled. To date, unlike the well-dissected bioenergetics, trafficking and broad metabolic adaptations of
an efferocyte, the epigenetic and transcriptional circuits that maintain these stable phenotypic changes
are unknown. Our objective is to define the key transcription factors and epigenome transitions that impart to
homeostatic MΦ a novel efferocytic state, adapt at continual AC clearance - in vitro and in tissue micro-
environment. We hypothesize that AC ingestion by homeostatic MΦ upregulates distinct transcription factors
which nucleate, in a feed-forward manner, novel enhancer-promoter interactions that establish efferocyte
identity. We further posit that GRIP1, an emerging key player in the homeostatic MΦ programming, facilitates
efferocytosis in vitro and in vivo. Our Specific Aims are to: 1) Identify AC-inducible drivers of efferocytosis in
distinct homeostatic MΦ populations; 2) Dissect epigenomic programming that transforms a homeostatic MΦ
into an efferocyte; 3) Decipher the role of GRIP1 in efferocytosis in vitro and in vivo. The successful completion
of this project will reveal the conserved global regulatory hubs enacting the transformation of homeostatic MΦ
into efferocytes by both discovering new players and delineating the role of GRIP1 in efferocytosis, from
molecular mechanisms to complex cell-cell interactions in tissue, in a relevant model of human disease.

Public health relevance
Every day, billions of apoptotic cells in the body are silently cleared by phagocytes in a homeostatic process termed ‘efferocytosis’, with its disruption linked to diseases such as diabetes-associated ulcers, unstable atherosclerotic plaques and autoimmunity. Macrophages are the main cell type giving rise to efferocytes by dramatically shifting their metabolism, bioenergetics and other intracellular processes however, the transcriptional and epigenomic circuits enabling these changes are unknown. The proposed study will help decipher epigenomic reprogramming of a macrophage to a stable efferocytic phenotype, which is critical knowledge needed to manipulate these cells in disease.